Clinical Epidemiology

CEU conducts research on etiology, natural history, multi-step carcinogenesis, and molecular characterization of cancers and precancers. Investigators focus on the discovery of risk markers and assay development and evaluation, with the goal of guiding promising markers into clinical and public health use. Risk markers may include genetics, epidemiologic factors, molecular biomarkers, imaging, or any routine clinical test. Investigators employ novel methods and technologies, such as artificial intelligence, methylation, and somatic mutation testing, in the context of rigorous population-based studies. We conduct comprehensive molecular characterization of cancer precursors, and we evaluate biomarkers in lesion-directed biospecimens.